Development and Implementation of Culturally Sensitive Safety Planning to Reduce Suicide Risk in Adolescents Seeking Care in Rural Emergency Departments

PROJECT SUMMART/ABSTRACT
One-in-five children and adolescents in the United States (US) live in rural areas where they experience
approximately two times the risk of suicide compared with their urban-residing peers. Despite having increased
rates of mental and behavioral health conditions, less than half of rural-residing youth with these conditions
receive necessary treatment, due in part to shortages of pediatric services and clinicians. Firearms are the
most lethal means of suicide, and high rates of firearm ownership in rural regions contribute further to rural-
urban disparities in youth suicide risk. Given barriers to community-based mental healthcare, youth with
suicidal ideation and/or attempt increasingly present to emergency departments (EDs) for care. While several
national organizations endorse safety planning (a brief intervention that involves identification of coping
strategies, social supports, and lethal means restriction) in EDs as an evidence-based suicide prevention
intervention, implementation in rural settings requires consideration of the cultural context as well as hospital
and community resources. The overall goal of this project is to develop and implement a technology-aided
approach to safety planning that will specifically address two social determinants of health – home safety and
access to community mental healthcare – to decrease suicide risk in youth 12-17 years of age who present to
rural EDs. To achieve this goal, investigators will: (i) conduct focus groups and interviews with rural-residing
youth, their caregivers, clinicians, and community members to ascertain their priorities and perspectives about
how to optimize safety planning, including lethal means counseling and community resource connections, in
rural EDs; (ii) apply principles of human centered co-design to develop and test a youth- and caregiver-facing
tablet-based digital intervention to guide safety planning, using mixed methods to investigate its feasibility,
acceptability, and appropriateness, and to evaluate participant-reported self-efficacy to improve suicide-related
coping and home safety (target mechanisms); and (iii) conduct a type 1 hybrid implementation-effectiveness
study using a hospital-randomized stepped wedge design in four rural EDs to determine the effectiveness of
this intervention compared to usual care for youth with suicidality, evaluating the extent to which outcomes are
mediated by caregiver and youth self-efficacy, and assessing the reach, adoption, implementation and
maintenance of the intervention using a mixed methods approach. Primary outcomes, measured one and three
months following the ED visit, will include youth-reported suicide risk, evaluated using a validated instrument,
and caregiver-reported access to firearms and medications within the home. These aims are directly aligned
with the goals of this funding announcement to “develop, adapt, or implement intervention strategies
addressing social determinants of health to improve health and promote health equity in rural populations,”
addressing critical rural-urban disparities in youth suicide risk and firearm mortality.

Public health relevance
NARRATIVE Children and adolescents who reside in rural regions of the United States experience substantially increased risks of mental and behavioral health conditions, suicide, and firearm-related deaths, and also experience unique barriers to care given geographic isolation and shortages of mental health professionals. This research will develop, implement, and evaluate technology-assisted, culturally sensitive safety planning in rural emergency departments for youth with suicidal ideation or attempt and their caregivers, aiming to improve home safety and connections to community-based resources and ultimately decrease youth suicide risk.